Role of Runx2 in Postnatal Dentin Synthesis and Alveolar Osteogenesis

Abstract
Tooth and alveolar bone health are essential for proper oral functions of feeding, chewing, speaking, and other
essential activities of daily life. Alveolar bone loss due to periodontitis and tooth cracking are the second and
third most common reasons for tooth loss. Elucidating the molecular regulation of dentin synthesis and alveolar
osteogenesis will contribute to filling the significant knowledge gap and finding new molecules to target for
therapeutics. The runt related transcription factor 2 (Runx2) is the master regulator of skeletogenesis. Humans
harboring mutations in the RUNX2 gene exhibit cleidocranial dysplasia, which is characterized by both dental
and various skeletal anomalies. Global deletion of Runx2 gene in mice results in complete failure of ossification
and embryonic lethality. Our previous work has demonstrated that Runx2 is required for the differentiation of
the resting chondrocytes to hypertrophic chondrocytes and endochondral ossification. We have also shown
that Runx2 gene deletion in developing osteoblasts impairs the postnatal synthesis of long bone and the
acquisition of adult bone mass. Our preliminary data show a surprisingly significant increase in dentin
synthesis in mice with Runx2-deficient odontoblasts and a concomitant decrease in bone synthesis and bone
mass by Runx2-deficient osteoblasts. Furthermore, the microenvironments of alveolar osteoblasts compared to
long bone osteoblasts are fundamentally different. These osteoblasts have different origins, pathogen
exposure, and loading forces. Therefore, we hypothesize that Runx2 is required for postnatal dentin
synthesis and alveolar osteogenesis. We further postulate that the gene expression profiles of alveolar and
long bone osteoblasts are fundamentally different.
We will experimentally test these hypotheses in the following proposed aims: In Aim 1, we plan to elucidate the
regulatory role of Runx2 in committed odontoblasts for dentin synthesis. Aim 2 is focused on determining the
critical differences in Runx2 regulated alveolar and long bone osteogenesis. The proposed experiments will
utilize unique mouse models to answer fundamental mechanistic questions about the differential regulation of
dentin and alveolar bone synthesis by Runx2. This application builds on a strong interdisciplinary scientific
environment and institutional support to train successful clinician-scientists in the field of oral and maxillofacial
regeneration. This combination is necessary for my goals of becoming an independent researcher as an oral
and maxillofacial surgeon-scientist. The findings from the proposed experiments will uncover Runx2-regulated
pathways that could serve as therapeutic targets for dentin and alveolar bone repair and regeneration.
Additionally, understanding the functional differences between alveolar and long bone osteoblasts will enhance
craniofacial and orthopedic therapies.

Public health relevance
Project Narrative Alveolar bone and periodontal bone loss and tooth fractures are common and require costly repairs. Low alveolar bone mass often results in tooth loss, implant failure, difficulty with chewing and speaking, and psychological insecurities. Elucidating the molecular mechanism by which odontoblasts and osteoblasts contribute to the mineralized matrix in the teeth and jaw bones may open new therapeutic targets for patients with dentin and alveolar bone defects.